Elucidating the molecular basis for conoid extrusion in Toxoplasma gondii

ABSTRACT
Chronically infecting a third of the world’s population, Toxoplasma gondii (T. gondii) is the most
successful human pathogen. The parasite owes part of its success to a specialized apical
structure that is built to assist host cell invasion. This apical complex contains a tubulin-based
organelle called the conoid which becomes extruded during cell motility by an unknown
mechanism involving actin, myosin (MyoH) and a formin (formin 1). The goal of this proposal is
to reconstitute these core elements of the apical complex in vitro to gain a mechanistic
understanding of how the conoid is extruded. In our previous study (published in Nature
Communications), we visualized the polymerization of individual T. gondii actin filaments in real
time. This work will be the basis for studying the properties of formin 1 and MyoH. In Aim 1, we
will study the biophysical features of MyoH and determine if force generation is necessary for
conoid extrusion. In Aim 2, we will visualize the nucleation of T. gondii actin from formin 1 in vitro
and then reconstitute the protein with MyoH and actin to directly visualize how these components
cooperate to drive conoid extrusion. By taking a biophysical approach, results to these studies
will provide long sought after mechanistic details of conoid extrusion and cell motility, which will
greatly inform future development of next generation drugs that target these essential proteins.

Public health relevance
PROJECT NARRATIVE Toxoplasma gondii is the causative agent of Toxoplasmosis, a life-threatening disease in immunocompromised individuals and when infection occurs in utero. Survival of the parasite relies upon a motile organelle called the conoid for host cell invasion and motility. This proposal seeks to understand how actin and myosin produce force for apical conoid extrusion at a molecular level, which will pave the way for targeted drug development.